An Orbitrap Astral Mass Spectrometer for Elevating Proteomics Sensitivity at Rutgers Biomedical and Health Sciences Newark Campus

Project Summary/Abstract
The Rutgers Biomedical and Health Sciences (RBHS) seeks NIH support to acquire a Thermo Orbitrap Astral mass
spectrometer (Astral MS) for the Center for Advanced Proteomics Research (CAPR) on its Newark campus. CAPR
supports over 150 NIH-sponsored projects. The influx of research grants at Rutgers, growing from $644 million to
$929 million from FY14 to FY24, has increased demand for mass spectrometry services at CAPR. While once
cutting-edge, the existing Thermo Lumos Tribrid MS is now inadequate for many sensitivity-demanding projects
due to its limited sensitivity and impending obsolescence.
The Astral MS, with its enhanced data-independent acquisition (DIA) sensitivity, can detect over 10,000 human
proteins, a crucial capability for integrating proteomic data with RNA-seq and discovering changes in protein
expression and post-translational modifications. It also significantly improves data-dependent analysis of
immunopeptidomes, a vital aspect of cancer immunotherapy and vaccine development, by detecting low-
abundance peptides more effectively. Comparative evaluations revealed the superiority of the Astral MS in
identifying low-abundance proteins and peptides compared to the Lumos and new Bruker timsTOF Ultra MS. The
Astral MS detected over 60% more phosphopeptides and 100% more proteins than the Lumos MS and significantly
more immunopeptides, highlighting its potential to revolutionize CAPR proteomic research support capabilities.
Operational practicalities have been thoroughly considered, with a smooth integration of the Astral MS anticipated,
given CAPR's familiarity with Thermo instruments and software. CAPR is confident in the substantial benefits that
this instrument's exceptional sensitivity and speed enhancements will bring, bolstering sensitivity and service
capacity for the users. Incorporating an Astral MS will effectively address sensitivity requirements among our 16
major users and 10 minor users, who have substantiated their needs for this new instrument based on the scientific
aims of their NIH-funded research projects. Acquiring a Thermo Orbitrap Astral mass spectrometer is critical for
CAPR to continue supporting NIH-funded investigations, enhance their DIA quantification sensitivity and DDA
immunopeptidome sensitivity, and stay at the forefront of the rapidly evolving proteomics field.

Public health relevance
Project Narrative This application proposes to purchase a high-end mass spectrometer to support a strong cohort of NIH-funded researchers at Rutgers University Newark Campus and nearby institutions. This new instrument allows our researchers to speed up their biomedical research by detecting more changes in proteins in cells and tissues. Thus, adding this instrument to Rutgers Center for Advanced Proteomics Research is critical in improving our research productivity and the capacity to remedy human diseases, including infections, cancer, heart ailments, and brain diseases.